Task A78: Mouse and guinea pig models for cytomegalovirus

This contract provides for the development and standardization of small animal models of infectious diseases, and may include efficacy testing of candidate products, including GLP studies to support licensure.